B Cell/T Cell Interactions in Brucellosis

Project Summary/Abstract
In humans, Brucella spp. can cause a lifelong, debilitating disease, with relapses of undulating fever and
other complications even with antibiotic treatment. No vaccines are currently licensed to prevent human
brucellosis, and mechanisms underlying the ability of Brucella to cause chronic infection are not well known. We
have found B cells enhance susceptibility to Brucella infection by inhibiting CD4+ T cell-mediated immunity. In
this proposal, we will test the hypothesis that B cell antigen presentation skews the CD4+ T cell response during
brucellosis which impairs vaccine efficacy and contributes to chronicity of infection. In Aim #1 of this proposal
we will investigate mechanisms by which B cell antigen presentation affects control of infection and modulates
differentiation of CD4+ T cells into Th1, Th17, or regulatory T cells. In Aim #2 of this proposal, we determine how
follicular interactions between B and CD4+ T cells affect antibody production and CD4+ T cell function and
determine the relative contribution of IgG and IgM to immunity to infection. Collectively, our results will enhance
our knowledge of the pathogenesis of chronic brucellosis and identify immunomodulatory strategies that can be
incorporated into the rational design of brucellosis vaccines

Public health relevance
PROJECT NARRATIVE Brucella infections can cause debilitating disease with relapses of an undulating fever and lifelong complications even with antibiotic treatment; however, mechanisms underlying Brucella’s ability to cause chronic infection remain largely unknown. We have found B cells enhance susceptibility to Brucella by skewing CD4+ T cell responses, and in the proposed studies we will investigate the mechanisms by which B cells modulate CD4+ T cell responses to enhance susceptibility to Brucella infection. Collectively, our results will enhance our knowledge of the pathogenesis of chronic brucellosis and should also have implications for future rational design of Brucella vaccines.